The Ante-Amyloid Treatment of Alzheimer's disease (A3) Trial and Alzheimer Plasma EXtension (APEX) Study

SUMMARY: This R01 application is to continue NIH funding for the Ante-Amyloid treatment of Alzheimer’s
disease (A3) Trial and the Alzheimer Plasma Extension (APEX) Study. The A3 Trial is one of the sister
trials of the AHEAD 3-45 Study testing lecanemab, a potent amyloid-removing monoclonal antibody, at the
asymptomatic or “preclinical” stage of AD. The overall goal of these studies is to build a “bridging chain of
evidence” that will link the removal of very early amyloid-beta (Aβ) to slowing the spread of early AD tauopathy
and ultimately to the prevention of cognitive decline that occurs in the later stages of AD. The A3 testing is low
dose lecanemab, prior (“ante”) to elevated brain amyloidosis, defined by intermediate levels (20-40 Centiloids)
on screening Aβ PET. A3 runs in parallel with “A45” Trial, testing higher dose lecanemab in participants at later
stages of preclinical AD (>40CL). The A3 Trial is the first prevention trial to test an amyloid-lowering
therapeutic at the intermediate amyloid stage of sporadic AD and will contribute essential knowledge about the
optimal window for efficacy and safety of anti-amyloid monotherapy. A3 is primarily an imaging and biofluid
Phase IIb Study at a very early stage of AD pathophysiology, and will require longer term cognitive and
functional assessments, paired with biofluid and imaging outcomes, through the Open-Label Extension. This
A3 evidence will serve to elucidate the links between Aβ, tau, and the cognitive decline expected at the later
preclinical stages studied in the A45 trial. The AHEAD 3-45 Study screened over 20,000 individuals ages 55-
80, and recently completed randomization of (N=441) and A45 (N=1146), utilizing a novel plasma screening
algorithm. The APEX Study, funded as a supplement to the A3 R01, will follow 1000 participants with subtle
plasma abnormalities, but were not eligible for randomization due to amyloid PET below the A3 threshold
(<20CL). APEX is oversampling from a large group of individuals from minoritized racial and/or ethnic
underrepresented groups (URG), who showed disproportionate rates of ineligibility on screening Aβ and tau
markers. APEX (currently >50% URG enrollment) provides an unparalleled opportunity to evaluate longitudinal
trajectories of AD biomarkers across ethnoracial groups to inform future primary AD prevention trials.
Furthermore, across APEX and A3-45, we will evaluate Social Determinants of Health, and novel markers of
vascular and inflammatory processes to evaluate independent (and Aβ interactive) contributions to cognitive
decline. This will lay the foundation for future prevention trials in more representative populations in whom Aβ
may not be the primary driver of dementia. Completing these public-private-philanthropic ACTC partnership
projects will provide critical information to the field, in particular whether lowering Aβ at this much earlier stage
of disease can halt the spread of tauopathy and have a greater impact on cognitive decline. These studies will
serve to chart the path forward towards primary prevention of AD, as well as combination prevention trials to
address the multiple contributors to cognitive decline in older individuals.

Public health relevance
NARRATIVE The A3 Trial will test an anti-amyloid treatment aimed at reducing amyloid and slowing tau accumulation, the hallmark pathologies of Alzheimer’s disease, in individuals who are not (yet) “amyloid-positive”. The A3 Trial is the first of its kind trial in asymptomatic older individuals with intermediate levels of brain amyloid, at high risk for future brain amyloid accumulation. The APEX Study is the companion observational arm that follows a diverse group of participants with blood markers suggestive of early amyloid but still below the intermediate level of amyloid PET. The goal of these studies is to build the “chain of evidence” that lowering amyloid can slow the progression of tangle pathology, neuronal loss, and eventual memory decline due to Alzheimer’s disease. These projects have potential public health impact as 10,000 baby boomers enter the age of risk for AD every day in the United States.